Endothelial Cell vs Immune Cell Contribution to Atherosclerotic Plaque Inflammation Post Preeclampsia

PROJECT SUMMARY
Preeclampsia (PE) affects 2-8% of pregnancies worldwide and is diagnosed as new-onset hypertension with
signs of target organ damage. Women that survive PE are twice as likely to experience atherosclerosis-related
conditions (coronary heart disease) leading to ischemic events (myocardial infarction and stroke) compared with
women who have uncomplicated pregnancies. Epidemiological studies indicate residual risk for cardiovascular
disease following PE that is not explained by pre-existing risk factors. Systemic vascular endothelial cell (EC)
dysfunction and increased immune cell activation are correlated with PE and can persist sub-clinically in the
years following pregnancy. Activated and dysfunctional ECs augment immune cell recruitment into the vascular
wall contributing to atherosclerosis, but the effect of PE on mechanisms of atherosclerosis and the role of pre-
existing risk factors remains a gap in knowledge. To understand the specific effect of PE, a well-established
experimental mouse model known to elicit features seen in humans (soluble fms-like tyrosine kinase 1 (sFlt-1)
adenoviral injection mid-gestation) will be studied, compared with a control pregnancy (empty vector adenovirus).
Preliminary data demonstrate that mice exposed to experimental PE have 1) microvascular EC dysfunction in
late gestation and 8 weeks postpartum and 2) increased number of leukocytes and T cells in atherosclerotic
plaques 8 weeks postpartum, independent of plaque size, lipid content, necrotic core, or metabolic risk factors.
Importantly, increased plaque inflammation contributes greatly to plaque instability and likelihood of rupture
leading to ischemic events. Therefore, the hypothesis is that enhanced atherosclerotic plaque inflammation after
PE is due to persistent, systemic vascular EC activation and dysfunction combined with increased
proinflammatory immune cell activation and infiltration into atherosclerotic plaques. Aim 1 will test if experimental
PE results in persistent EC activation, microvascular function, and large artery stiffness in atheroprone mice
(LDLr-/- mice fed a high fat diet postpartum). EC activation will be assessed via immunofluorescence in
mesenteric resistance arteries (microvasculature) and areas of atherosclerotic plaque development. EC
dysfunction will be assessed ex vivo via wire myography, and large artery stiffness will be assessed in vivo via
pulse wave velocity in late gestation, 4 weeks postpartum, and 8 weeks postpartum. Aim 2 will determine how
experimental PE alters immune cell plaque inflammation using single cell RNA sequencing to determine
alterations in subpopulations, cell states, gene expression, and cell-cell interactions in aortic plaques 8 weeks
following PE in atheroprone mice. Completion of project aims will provide mechanisms of atherosclerosis EC
dysfunction and leukocyte infiltration following PE, which can be used to investigate targeted prevention
strategies and therapeutics in future work. This F32 fellowship also provides extensive training opportunities in
basic science and professional development to support the applicant’s long-term goal of becoming an
independent academic researcher studying female-specific cardiovascular health across the lifespan.

Public health relevance
PROJECT NARRATIVE This project addresses a relevant public health concern as preeclampsia is one of the most common pregnancy complications and is considered a significant risk factor for future atherosclerosis and ischemic events. Using a combined mouse model of experimental preeclampsia and atherosclerosis, this project seeks to understand preeclampsia-specific vascular and immune mechanisms that contribute to enhanced atherosclerotic plaque inflammation following preeclampsia. Results from this study can contribute to the development of targeted therapeutics to mitigate preeclampsia-associated cardiovascular disease, which is identified by the National Heart Lung and Blood Institute (NHLBI) as high priority topic.